Metals, the Microbiome, and Kidney Health Among Adolescents in Central America

ABSTRACT
Chronic kidney disease of unknown etiology (CKDu) is a deadly disease among young people in
Central America, especially agricultural workers. Risk factors and presentation of this disease are distinct from
that of traditional CKD; metal exposure is a hypothesized CKDu risk factor and is of concern in regions of
Nicaragua due to volcanic bedrock and industrial practices. Among youth, metal exposure is known to interfere
with developmental processes affecting organ and system function, contributing to deficits across the life
course. Likewise, metals have been shown to affect the microbiome, which plays a role in kidney function and
disease. Our work displays evidence of kidney injury in non-working young people in Nicaraguan regions with
high adult prevalence of CKDu, and we hypothesize that disease processes initiate in youth before
occupational exposures. Our longitudinal cohort “Jovenes-Nica Study” has enrolled over 400 youth across
Nicaragua for three rounds of follow-up from 2022-2024. At each round, biological samples and a health
survey are collected to assess exposures, kidney function, and overall health status of participants. In this
proposal, we will apply sophisticated analytical methods to evaluate the associations between biomarkers of
metal exposure and renal endpoints in youth at high risk of CKDu, while considering the urinary microbiome as
a key intermediary on the exposure-disease pathway. Though understudied in comparison to other human
microbiomes, the urinary microbiome has been associated with kidney health.
Ms. Samantha Hall (PI) proposes the following research activities under the dedicated mentorship of
experts in environmental epidemiology, biostatistics, mixtures modeling, and microbiome analysis. We will use
a portable x-ray fluorescent analyzer to quantify toenail metal concentrations. Flexible mixtures models like
quantile-based g-computation and Bayesian kernel machine regression will be used to explore associations
between metals (arsenic, cadmium, lead, mercury) and kidney function, modeled as estimated glomerular
filtration rate (eGFR) (Aim 1). Machine learning techniques, such as principal components analysis and
microbial co-occurrence network models, will detail the composition and diversity indices of urinary microbiome
samples in relation to metal exposure (Aim 2) and eGFR (Aim 3). The proposed training plan will expand Ms.
Hall’s existing skillset through the implementation of novel methods to understand highly dimensional exposure
and microbiome data. This work will address an important research gap by providing the first data to date on
any association between an environmental exposure and the urinary microbiome, as well as the first analysis
concerning the microbiome and renal health among youth in Central America. Our results will shed light on
unexplored pathways of disease for those at high risk of CKDu with applications for early disease intervention.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease of unknown etiology (CKDu) is a global public health crisis with high morbidity and mortality in Central America, and Nicaraguan youth in regions with high adult CKDu prevalence have shown evidence of kidney injury. Nephrotoxic metals have been associated with CKDu in adults and are arguably more toxic to youth given ongoing development of organ systems, though no prior studies have assessed environmental exposures in this high-risk group of young people. While changes in the human microbiome have been associated with both metal exposure and renal health in other populations, we propose the first study to consider metal exposure, the urinary microbiome, and renal function in Central American youth, results of which may inform early CKDu detection and intervention efforts.